Cellular and Synaptic Hypothalamic Reorganization After Exercise Training

Physical activity provides multiple metabolic benefits, including improved insulin sensitivity and body
composition. Within the brain, less is known about the effects of exercise to acutely alter synaptic/cellular
properties and how these effects contribute to altered metabolism. In the current proposal, we have found that
CNS derived GLP-1 neurons are activated in response to exercise. Moreover, GLP-1 and GLP-1 mimetics
mimic the effects of exercise on arcuate melanocortin neurons. Collectively, these data support the hypothesis
that an NTS GLP-1 to arcuate POMC circuit is activated in response to exercise. We will identify cellular
mechanisms through which exercise activates GLP-1 and melanocortin neurons. We will also determine a role
for these acute/chronic cellular mechanisms to regulate metabolism.

Public health relevance
The proposed studies will greatly increase our understanding of the acute mechanisms underlying GLP-1 dependent regulation in the brain. The study findings will allow us to learn how to better co-opt the mechanisms by which GLP-1 and exercise promotes improvements to metabolism. Moreover, these data are likely to have clinical implications for diabetes research as GLP-1 receptor agonists are common therapeutics in diabetes treatment/management.